Practical Applications to advance Minnesotas response to emerging issues initiated through sampling

Project Abstract
This cooperative agreement is intended to provide funding to the Minnesota Department of
Agriculture (MDA) Food and Feed Safety Division (FFSD) to advance public health by building
the capacity and capability of MDA-FFSD to take the appropriate action in response to
confirmed and potentially violative samples identified as part of the Laboratory Flexible Funding
Model (LFFM) cooperative agreement.
The Minnesota Department of Agriculture (MDA) Food and Feed Safety Division (FFSD)
licenses and inspects approximately 10,000 food facilities including 2,000 manufactured food
facilities in Minnesota. The MDA-FFSD has a dedicated Manufactured Food Program
responsible for manufactured food licensing, compliance, and inspection activities. The
Manufactured Food Program has 15 staff members including one program manager, two food
supervisors, one dedicated support person, and 11 field inspectors. FFSD has an additional 20
staff that fully or partially support the Manufactured Food Program in administrative capacities.
The MDA-FFSD, as part of this application, will apply MFRPS response and regulatory
framework to conduct follow-up inspections and investigations to violative samples; evaluate
training and auditing programs to ensure staff are qualified to respond to violative samples; build
infrastructure to investigate and respond to violative samples; engage in IT-data exchange
development; and increase use of best practices for enhanced coordination between FDA,
MDA-FFSD, and the Laboratory.

Public health relevance
Project Narrative The Minnesota Department of Agriculture (MDA) Food and Feed Safety Division (FFSD) seeks to advance public health by building the capacity and capability of MDA-FFSD to take the appropriate action in response to confirmed and potentially violative samples identified as part of the Laboratory Flexible Funding Model (LFFM) cooperative agreement. The MDA-FFSD, as part of this application will: apply MFRPS response and regulatory framework to conduct follow- up inspections and investigations to violative samples; evaluate training and auditing programs to ensure staff are qualified to respond to violative samples; build infrastructure to investigate and respond to violative samples; engage in IT-data exchange development; and increase use of best practices for enhanced coordination between FDA, MDA-FFSD, and the Laboratory.